Impact of DNA Repair Pathway Interactions on the Molecular and Physiological Consequences of Methylation Damage

Project Summary/Abstract
Here, we propose to study cancer etiology in the context of DNA damage caused by a methylating agent, N-
nitrosodimethylamine (NDMA), a probable human carcinogen that has been found in water, food, and drugs.
NDMA is both mutagenic and toxic, and our overriding hypothesis is that its biological consequences are shaped
interactions among three repair pathways: direct reversal, mismatch repair (MMR), and homologous
recombination (HR). One of the key DNA lesions created by NDMA is O6MeG, which mispairs readily with
thymine. The direct reversal protein O6-methylguanine DNA methyltransferase (MGMT) removes the offending
methyl group, restoring the structure of guanine. Interestingly, O6MeG can become toxic when acted upon by
Mismatch Repair (MMR), although the underlying mechanism remains to be fully elucidated in vivo. Normally,
MMR recognizes mismatches behind the replication fork and removes the newly synthesized strand to give the
cell another chance at accurate replication. In the case of O6MeG, it has been posited that MMR removes the
strand opposite the lesion forming a single strand gap that upon the subsequent replication cycle becomes a
broken fork (i.e., a double strand break [DSB]) that requires HR for repair. Despite the prevalence of this model
in the literature, these predicted processes have been largely untested in vivo, a key gap in the literature that will
be addressed in part by using an in-house genetically engineered mouse model, namely RaDR, for which HR
yields a fluorescent signal. An advantage of RaDR is that it can also be used for lineage tracing, which makes it
possible to monitor clonal expansion. Using the RaDR mice, we made the remarkable discovery that MGMT
strongly suppresses clonal expansion. Our overriding hypothesis is that MMR promotes toxicity and
inflammation, providing selective pressure for clonal expansion. Specific Aim 1 is to test the MMR model by
measuring the replication dependence of DSBs and HR to elucidate possible dependence on two cycles of
replication, which would be consistent with gap-driven fork breakdown. Specific Aim 2 is to quantify clonal
expansion, to leverage 2-photon microscopy for whole-organ 3D imaging of clonal outgrowths, and to peer into
clonal outgrowths via spatial transcriptomics to reveal underlying mechanisms of clonal expansion. Specific Aim
3 is to quantify the impact of MGMT, MMR, and their interaction on NDMA-induced inflammation and cancer in
the liver. The proposed work will not only elucidate the ways by which interactions among DNA repair pathways
modulate susceptibility to DNA damage, but it will also be one of the first studies of how DNA repair shapes the
risk of clonal expansion, a fundamentally important step in carcinogenesis. Together, these studies will have a
significant and lasting impact by advancing our understanding of the molecular forces that shape disease with
important implications to public health and the clinic.

Public health relevance
Project Narrative/Relevance Environmental carcinogens that damage DNA promote cancer and so our cells have multiple DNA repair pathways. Importantly, each repair pathway does not operate independently, and so we propose to study how interactions among different DNA repair activities shape the biological consequences of exposure to DNA damage in animal models. The results of this work will give rise to a deeper understanding of how cells react to DNA damage caused by an environmental carcinogen, and this will pave the way toward better ways to predict and prevent cancer.